Top-down modulation of the dorsal cochlear nucleus

PROJECT SUMMARY
An animal’s survival depends on their accurate perception of biologically relevant sounds in a complex
hearing environment that is awash with background noise. Top-down contextual information modulates the
processing of bottom-up sensory signals at multiple levels of the auditory pathway to improve hearing
accuracy, but the neural mechanisms underlying this essential function remain unclear, especially at the
earliest processing level in central auditory system. Here we examine the role of the massive top-down
projection from the inferior colliculus (IC) to the dorsal cochlear nucleus (DCN). Our overarching hypothesis is
that top-down signals that encode contextual information are conveyed to DCN by descending IC projections to
guide context-dependent filtering. The proposed project will reveal the circuit mechanisms of top-down
modulation at the first level of auditory processing in the central nervous system. This work could provide
insight into ways to improve auditory perception when bottom-up signals are degraded due to hearing loss, as
well auditory processing disorders for which top-down modulation has been implicated.
Early filtering that is guided by top-down modulation is a general principle in sensory systems.
Establishing how neural circuits implement context-dependent filtering has been difficult, due in part to a lack of
in vivo phenomenological studies being combined with circuit-level analysis. We will examine the neural
mechanisms underlying top-down modulation of the DCN by utilizing a powerful combination of (1) neural
circuit analysis using projection-specific retrograde tracing, (2) in vitro acute brain slice electrophysiology in
transgenic mice, and (3) cutting-edge in vivo electrophysiology and optogenetics in awake mice.
Aim 1 tests the hypothesis that DCN-projecting IC neurons are a subtype of small cells in the central nucleus,
by retrogradely labeling them and targeting them for direct electrophysiological and anatomical analyses.
Aim 2 tests how descending IC projections are processed by specific cells and microcircuits in DCN. We
recently discovered a pathway, through excitatory interneurons called unipolar brush cells, that could preserve
the descending tonotopic signals and extend their neural representation. This aim will test the hypothesis that
unipolar brush cells amplify signals to principal cells in DCN.
Aim 3 tests how descending IC projections shape auditory responses of DCN principal neurons in awake mice.
We will use optogenetic inhibition of DCN-projecting IC neurons to test their role in spontaneous firing rates,
frequency response properties, temporal response properties, and tone-in-noise detection thresholds.
Successful completion of this project will establish how top-down projections from IC modulate
auditory responses in the first level of auditory processing in the brain and will reveal the circuit mechanisms
that contribute to accurate auditory processing in complex sound environments.

Public health relevance
PROJECT NARRATIVE Top-down contextual information modulates the processing of bottom-up auditory signals to improve hearing accuracy, but the neural mechanisms underlying this essential function remain unclear, especially at the earliest level of the central auditory system. Here we use modern in vitro and in vivo approaches in mice to examine the role of the massive top-down projection from the inferior colliculus to the dorsal cochlear nucleus and test the cellular and circuit mechanism that guide context-dependent filtering of bottom-up signals. This project may provide insight into ways to improve auditory perception when bottom-up signals are degraded due to hearing loss, as well as auditory processing disorders for which dysfunctional top-down modulation has been implicated.